METHODOLOGICAL RESEARCH IN MATHEMATICAL STATISTICS AND BIOSTATISTICS

Methodological research in statistics is motivated often by interest in methodological/theoretical statistical questions. Consulting and collaborative projects also motivate the research because existing methods and theories may be inadequate to handle their data analysis or study design.